Wearable Wireless Respiratory Monitoring System that Detects and Predicts Opioid Induced Respiratory Depression

PROJECT SUMMARY. Opioids are the most prescribed drug in US hospitals, and opioid induced respiratory
depression (OIRD) is a widespread and life-threatening problem. Episodes of OIRD on the general hospital floor
are common, occurring in up to 46% of patients. Despite the prevalence of this problem, OIRD has yet to be
effectively addressed through monitoring technology. There is great clinical need for a wearable sensor capable
of detecting the onset and progression of OIRD with actionable alerts, well before the onset of severe
hypoventilation, hypoxemia, cardiac arrhythmia, and death. To meet this clinical need, RTM Vital Signs, LLC is
developing a wearable, wireless Respiratory Monitoring System (RMS) with an acoustic Trachea Sound
Sensor (TSS) and a software algorithm that continuously measures a person’s respiratory rate (RR), tidal
volume (TV), minute ventilation (MV), breathing pattern, duration of apnea, oxygen saturation, degree of
snoring, heart rate (HR), body position, and activity level. The RMS algorithm calculates a Risk Index Score
(RIS) specifically for OIRD every 20 seconds. RTM has received Breakthrough Device Designation from the FDA
to develop the RMS for the prevention of an opioid overdose and death in hospitalized patients, outpatients, and
US citizens that chronically use or abuse opioids. RTM plans to commercialize the RMS first for monitoring
hospitalized patients managed with opioids on the general nursing floors, due to the high incidence of OIRD in
these environments and the impracticality of using existing methods such as pulse oximetry combined with
capnography to provide sufficient monitoring for all patients receiving opioids. Having already demonstrated
feasibility of our technology, we are working to optimize the RMS to handle noisy environments and validate the
system in a clinical study. In Phase 1, we will optimize the existing RMS with dynamic filtering and active noise
cancellation software (Phase 1, Aim 1) and conduct a human study using the optimized RMS to measure the
accuracy of RR, TV, and apnea duration in a noisy environment with the filtering/noise cancellation software
turned on, versus turned off (Phase 1, Aim 2). In Phase 2, we will construct and bench-test functional RMS prior
to a human clinical trial (Phase 2, Aim 1), obtain an FDA Investigational Device Exemption (IDE), and then
conduct an observational clinical trial in post-operative surgical patients managed with fentanyl and other opioids
to demonstrate RMS’s ability to detect and predict the onset and progression of an OIRD event (n = 120 patients)
(Phase 2, Aim 2). Together, these steps will accomplish key development milestones and clinical testing needed
for regulatory approval and commercialization of the RMS device. Successful completion of this project will
produce a commercially viable wearable wireless RMS with the potential to improve the health and safety
of patients receiving opioids by accurately detecting and predicting OIRD with actionable alerts prior to
the onset of severe hypoventilation, hypoxemia, cardiac arrhythmia, and death.

Public health relevance
PROJECT NARRATIVE. Despite the high prevalence and life-threating nature of opioid induced respiratory depression (OIRD), current strategies to monitor for signs of OIRD are not suitable for deployment for all patients receiving opioids. To address the critical clinical need for technology capable of detecting the onset and progression of OIRD, RTM Vital Signs, LLC is developing a wearable, wireless sensor that continuously monitors a patients’ respiratory patterns to provide actionable alerts. By developing and validating this novel monitoring strategy for OIRD, RTM Vital Signs will ultimately improve patient outcomes and avoid adverse events including hypoventilation, hypoxemia, cardiac arrhythmia, and death.